eLwazi Open Data Science Platform and Coordinating Center

Project Summary/Abstract
The Open Data Science Platform (ODSP) and Coordinating Center (CC) for DS-I Africa is led
by a well-established partnership between Prof Mulder (current PI H3ABioNet) and Dr Michelle
Skelton (current Coordinator, H3Africa CC) hosted within the Computational Biology Division
and IDM at the University of Cape Town (UCT). Using 8 years of experience in leading a pan
African informatics consortium aimed at data and informatics resource and capacity
development, Mulder will establish the ODSP gateway and its eLwazi platform, a flexible,
scalable African open data science platform for depositing, sharing and accessing data,
selecting data-specific tools and data science methods, and deploying tools and workflows on
a choice of computing environments suited to the African context, facilitating novel discoveries
for health. Skelton will use her 7 years of experience in coordinating the large H3Africa
consortium to develop an efficient CC addressing all the joint administrative, collaborative and
logistical needs of the consortium.
Together, this formidable pair will transition their current teams and activities from H3Africa to
DS-I Africa, wrapping up one and starting the new, complementary endeavour with highly
experienced teams ready to provide immediate impact. They will support each other’s
activities, technically from the ODSP and operationally/logistically from the CC and co-develop
an effective data science and professional development training program. ODSP will support
the CC on website and tool development, while the CC will support ODSP in events planning,
managing data deposition, access policies and agreements and integration with the DS-I
Africa consortium.
The outcomes will be: 1) an open, transparent and sustainable ODSP developed with user
input to ensure their needs are met, accompanied by adequate user and administrative
support; 2) access to a choice of public and private Cloud and local African computing facilities
for data storage and analysis; 3) access to a comprehensive set of African and other relevant
datasets, tools/workflows and resources required for the implementation of data science
techniques to biomedical data; 4) a comprehensive data science and professional
development training program; 5) consolidated consortium policies, documents and
resources; 6) efficiently organized consortium activities, workshops and events; 7) avenues
for exploration of new collaborative and translational ideas and partnerships with industry and
other stakeholders. Collectively these provide the elements required for a fully supported
cohesive consortium facilitating the application of data science to health. The ODSP and CC
are African led, developed in Africa by Africans and for the benefit of African scientists and
research participants.

Public health relevance
Project Narrative The ODSP will develop a flexible, scalable open data science platform for the DSI-Africa consortium to find and access data, select tools and workflows and run analyses on a choice of computing environments, all through easy to use workspaces. Administration and support of the core resources and consortium activities will be coordinated by the CC. Together, the ODSP and CC will provide an infrastructure for researchers to use data science technologies to deliver cutting edge biomedical research for health, while promoting cohesion, collaborative cross-consortium activities and engagement with external stakeholders to facilitate innovation and translation.